North Texas ADRC - Admin Core

The Administrative Core will provide leadership to the North Texas Alzheimer’s Disease Research Center (NT-
ADRC). The core will oversee the center’s activities to achieve its mission of strengthening Alzheimer’s
Disease and Related Dementias (AD/ADRD) research, enhancing clinical and educational activities in the
North Texas area, and contributing to the national network of ADRCs. We are building our center by leveraging
multiple ongoing research programs and initiatives. There is a strong institutional commitment for establishing
highly innovative multidisciplinary neuroscience programs, including the proposed NT-ADRC. We structured
the Administrative Core to serve the center’s key mission and activities and to serve as a hub for Internal and
external connections. The Director and the Executive Committee will oversee the proper utilization of the
center’s resources, ensuring their use has the maximum impact on the AD/ADRD field and accomplishes our
center’s aims. The Executive Committee has the critical role of advising the Director in making scientific and
administrative decisions related to the center. They will facilitate building the network of collaborative scientists
and clinicians who will work towards accomplishing the center’s aims. The Administrative Core aims are to: 1.
provide governance of the NT-ADRC by planning, coordinating, and integrating all activities of the center; 2.
promote innovative and cutting-edge research through creating an internal funding program and participating in
recruitment and retention of investigators and faculty; 3. facilitate internal and external data and biospecimen
sharing; 4.create opportunities for interaction, networking, exchange of ideas, and result dissemination; and 5.
to create a culture of the highest scientific integrity. The Administrative Core will set the center’s research
priorities, encourage new innovative lines of research and interactions between the center cores and
investigators at all levels, and serve as a central location for dissemination of knowledge to the local scientific
and lay communities. The Administrative Core will also coordinate visits and work closely with the Internal and
External Advisory Committees to further enhance our work towards the global aim of finding effective therapies
for these disabling diseases.